Cocaine exposed children--Cardiac problems and outcomes

This pilot study proposes to study older children (age 2 to 4 years) in order to determine if perinatal cocaine exposure leads to persistent cardiac (ST segment elevation and left ventricular hypertrophy) abnormalities.